Role of IL-32 as a predictor and mediator of Premature Aging Phenotypes(PAP) in HIV infection.

PROJECT SUMMARY
People living with HIV (PLWH) are aging and have increased risk for age-associated health complications such
as cardiovascular diseases (CVDs) and low bone mineral density. Both CVD and decreased bone mineral
density accelerate frailty, which is a complex of geriatric conditions underlying biological vulnerability and
decreased physiological competence that results in multiple adverse outcomes. Inflammation plays a critical
role in these ageassociated phenotypes. Identification of novel surrogate inflammatory biomarkers with
inherent potential as disease causative agents not only enhances risk stratification in the aging HIV+
populating but also offers important cues for novel therapeutic strategies. IL-32 is a multi-isoform
proinflammatory cytokine that we showed to be linked with CVD and aging in HIV infection and is negatively
regulated by the gut short chain fatty acid caproic acid. IL-32 is also involved in mechanisms governing bone
metabolism, mechanisms that are potentially involved in atherosclerosis. Here, we hypothesize that in HIV
infection, IL-32 is involved in Premature Aging Phenotypes (PAP) that are manifested by CVD, altered body
composition (low bone mineral density and abnormal fat deposition) and frailty. To validate this hypothesis, our
current applications proposes an approach combining in vivo cardiovascular imaging, ex vivo measures of IL-
32 from PLWH for whom frailty and body composition data are available, and in vitro studies intending to
investigate the mechanistic link between IL-32 expression and PAP. In Aim 1, we will study the expression of
IL-32 isoforms in peripheral blood in PLWH in two large cohorts of men and women; the Canadian HIV and
Aging Cohort Study (CHACS) and the Women's Interagency HIV Cohort Study (WIHS), now combined with the
Multicenter AIDS Cohort Study (MACS) in the MWCCS cohort, respectively. We will evaluate the potential of
IL-32 isoforms in predicting PAP in these two cohorts using two types of analysis; a binary analysis
(presence/absence of CVD, frailty and osteoporosis) and joint occurrence of the adverse phenotypes. In Aim 2,
we will investigate the mechanisms by which caproic acid regulates IL-32 expression in 3 major cell types;
intestinal epithelial cells (as a primary cell types expected to be exposed to caproic acid in gut), CD4 T cells
(major cells producing IL-32 and main reservoir for latent HIV under ART) and primary vascular endothelial
cells, the dysfunction of which results in frank atherosclerosis. In Aim 3, we further propose to dissect the
mechanism(s) by which the CVD-associated IL-32 isoforms impact the process of osteoclastogenesis
(differentiation of osteoclast cells involved in bone resorption, lower mineral bone density and potentially the
development of noncalcified atherosclerotic lesions). Together, the overarching goal of this project is to
demonstrate that IL-32 is a central player in systemic inflammation and an accelerator of multiple aging
phenotypes (CVD, frailty and osteoporosis) and that this cytokine can be used as a predictive biomarker for
PAP and also as a therapeutic target.

Public health relevance
PROJECT NARRATIVE People living with HIV (PLWH) are aging and experience a greater risk of age-related illness such as cardiovascular diseases (CVDs), bone diseases and frailty that appear to manifest at an earlier age (premature aging). We have identified the novel human inflammatory cytokine IL-32 as a key factor associated with CVD. The objective of this proposal is to study the potential impact of IL-32 on bone health and frailty, which will likely establish the link between HIV-mediated inflammation and premature aging of organs other than those involved in the immune response.